Improving Symptom Management for Adolescents and Young Adults with Advanced Cancer: Development and Pilot Testing of a Novel Intervention

Each year more than 30,000 adolescents and young adults (AYAs) aged 15 to 29 are diagnosed with cancer in
the United States. AYAs are more likely to present with advanced disease and more aggressive tumors, and
have worse prognosis when compared with younger and older cancer patients. AYAs with advanced cancer are
also challenged by high psychological (e.g., anxiety, depression) and physical (e.g., pain) symptom burden.
Despite this, AYAs with advanced cancer are underserved in palliative care. Adult palliative care services
primarily treat older cancer patients (mean age 60-65); thus, the majority of psychosocial symptom management
interventions have been tested among individuals aged >40. There too remains a gap in pediatric palliative care
for AYA patients where services are typically focused on the needs of patients aged <15. AYAs are diagnosed
during a critical developmental period when they are working to achieve complex, age-related goals (e.g.,
completing their educations, achieving autonomy, building their careers, fostering relationships, building
families). The combination of physical symptoms, psychological distress, and challenges to achieving
developmental milestones may exacerbate patient suffering; yet, the unique, age-related needs of AYAs with
advanced cancer often go unrecognized. The proposed project will begin to fill this gap. The study aims to
develop and test the feasibility and acceptability of a psychosocial symptom management intervention designed
to meet the unique needs of AYAs with advanced cancer. The proposed intervention will combine traditional
behavioral symptom management strategies commonly use in the palliative care setting with important skills and
concepts from Meaning-Centered Psychotherapy and Acceptance and Commitment Therapy. Skills from these
approaches may be particularly relevant to AYAs with advanced cancer who experience significant disruption in
life goals from cancer and associated symptoms and may have greater difficulties understanding and finding
meaning in their lives than older and younger patients. Intervention content, structure, and study procedures will
be informed by qualitative data obtained during focus groups with patient (n=16) and caregiver (n=12)
stakeholders as well as review by patient user testers (n=3). It is anticipated that the intervention will include four
weekly sessions spaced over 6-8 weeks and be delivered using videoconferencing. Next, AYAs with advanced
cancer (N=40) will be randomized to the intervention or education control arms using an allocation ratio of 1.5:
1. We will examine the feasibility of study recruitment and retention, acceptability, and changes in variables of
interest (i.e., physical and psychological symptoms, symptom interference, self-efficacy for symptom
management, experiential avoidance, values) over time for the intervention and control arms. Participants will
also provide feedback on study materials, intervention format, and the appropriateness of the intervention to the
population and advanced stage of disease. Information obtained from this pilot study will well position the PI and
investigative team to examine the efficacy of the developed intervention in a larger randomized controlled trial.

Public health relevance
Relevance Statement Adolescents and young adults (AYAs; aged 15-29) with advanced cancer are underserved in palliative care despite being more likely to present with advanced disease and to have high symptom (e.g., pain, fatigue, psychological distress) burden, more aggressive tumors, and worse prognosis when compared to younger or older oncology patients. Poor prognosis and the associated high symptom burden experienced by AYAs with advanced cancer can impact patients’ sense of identity and purpose in life as the goals towards which they had been working have been made more difficult if not impossible; this combination of high symptom burden and challenges to achieving developmental milestones may exacerbate patient suffering. The proposed research advances the wellbeing of AYAs with advanced cancer by developing and pilot testing a novel psychosocial symptom management intervention combining traditional behavioral symptom management strategies commonly used in the palliative care setting with important skills and concepts from Meaning-Centered Psychotherapy and Acceptance and Commitment Therapy; skills from these approaches may assist AYAs with better managing symptoms and facilitating engagement in personal value-directed activity.